Core 3: Biostatistics Core

PROJECT SUMMARY – CORE 3
The principal objective of the Biostatistics Core (Core 3) is to provide project investigators a centralized
resource for biostatistics expertise. Statistical issues will be addressed at all levels of investigation: from the
design of experiments and clinical trials, to the maintenance of data quality; and from conclusions based on
formal hypothesis testing, to important leads discovered by thorough data exploration. The specific aims of the
Core are: 1.1. Collaborate with project investigators in the formulation of unambiguous hypotheses and
hypothesis testing strategies, and in the design of experiments. Biostatistics collaboration will assist
researchers at the design stage by: formulating biological and clinical questions as testable statistical
hypotheses; devising efficient experimental designs and matching these with appropriate statistical models;
determining sample sizes necessary to ensure high power; and strongly controlling. 1.2. Provide support for
all projects with: formal hypothesis tests in experimental and clinical data that ensure strong
conclusions; exploratory analyses that lead to further experiments, refined hypotheses, or discoveries;
statistical modeling and sensitivity analyses of complex data; and visual displays of data that clarify
conclusions and uncover leads. Core 3 statisticians have worked extensively with investigators to develop
comprehensive analysis plans that distinguish between formal testing (which provides evidence for strong
conclusions based on prior scientific knowledge/experimentation) and exploratory analyses (which do not allow
for strong conclusions, but lay the groundwork for important discoveries). Core statisticians will employ the most
robust methods for modeling and sensitivity analyses to ensure reliability of results. For all data, visual displays
will be emphasized in order to reveal the reliability of conclusions and aid in the discovery of new leads. 1.3.
Provide data management and integration services that ensure high integrity, security and investigator
accessibility. Ensure statistical analysis consistency and transparency across projects, and have a
centralized repository of all analysis procedures and results. To promote data integration across projects,
Core 3 will have a centralized repository of all data that is secure and accessible to the investigators. Data will
be cleaned, merged and de-identified. All missing and outlying data will be reported to investigators. Core 3 will
ensure consistency of analysis plans and reports for the same data types across projects. 1.4. Develop new
statistical methodologies to directly combat complex data or design problems that arise in projects and
where current statistical methods do not apply. When faced with specific issues that arise in these projects
where current statistical methods do not apply, Core 3 personnel will either adjust available methods or develop
novel procedures to address the problems.

Public health relevance
PROJECT NARRATIVE – CORE 3 The Biostatistics Core will provide critical support for planning and design of experiments and studies, statistical analyses and display of data, and data management and integrity. This support is designed to ensure that studies yield reliable conclusions, resources are efficiently used, and exploratory analyses uncover important leads.